Regulation of Mammalian Meiotic Decision by Glutamine Transporter Slc38a2

PROJECT SUMMARY
Eukaryotes undergo two primary types of cell division: mitosis and meiosis. Somatic cells rely on mitosis to
generate genetically identical daughter cells, while germline cells possess the unique ability to transition from
mitosis to meiosis, producing haploid daughter cells with distinct genetic characteristics through meiotic
recombination and segregation. Despite the conservation of meiotic genes and chromosome structures across
yeasts to mammals, the signals initiating meiosis differ. Yeasts respond to nutrient restriction, which inactivates
TOR1/cAMP-dependent protein kinase A (PKA) signaling. On the other hand, mammals require retinoic acid
(RA), a chordate morphogen, to activate Stra8 (stimulated by retinoic acid gene 8) for meiosis. We propose a
hypothesis that aims to reconcile this evolutionary divergence: nutrient restriction, as a conserved signal, drives
meiosis from yeasts to mammals. Specifically, our previous study revealed that mammalian meiosis-initiating
cells are influenced by an in vivo autophagy-inducing factor. Subsequent research demonstrated that nutrient
restriction, a powerful inducer of autophagy and yeast meiosis as mentioned earlier, induces meiosis in cultured
mouse male germline stem cells (mGSCs). Interestingly, our recent transcriptomic study sheds light on how
mammalian germ cells "starve themselves" for meiosis in vivo. It shows that during meiotic initiation, nutrient
transporter expression is repressed, and this process is facilitated by retinoic acid (RA) and Stra8 through H3K27
deacetylation. Together, these findings suggest that, unlike yeast meiosis, which passively depends on
environmental nutrient conditions, mammalian germ cells actively withdraw their nutrient transporters to restrict
nutrient uptake and initiate meiosis. In this study, we will: 1) Investigate the role of mTORC1/PKA as signaling
hubs connecting Slc38a2 with meiotic initiation; 2) Characterize the metabolic mechanisms that Slc38a2 controls
meiotic initiation.

Public health relevance
PROJECT NARRATIVE How mammalian germ cells transition from mitotic and meiotic cell cycle is a fundamental biological question. In this study, the investigators will study nutrient restriction as an evolutionarily conserved driver of meiosis. In mammalian germ cells, nutrient restriction is achieved through the downregulation of nutrient transporter expression, among which glutamine transporter Slc38a2 is proposed as a key player in this process.